Mouse Biology Shared Resource

MOUSE BIOLOGY SHARED RESOURCE (MBSR)
PROJECT SUMMARY/ABSTRACT
The Mouse Biology Shared Resource (MBSR) provides unique, sophisticated, and comprehensive resources
and services using mutant mice and murine cancer models for basic and translational cancer research for UC
Davis Comprehensive Cancer Center (UCDCCC) members. The MBSR has provided research support to
cancer researchers at the UCDCCC since its inception. The MBSR offers scientific expertise, customer
assistance, technical training, specialized capabilities, unique services, and dedicated infrastructure for mouse
embryo manipulation, genome mutagenesis, husbandry, production, phenotyping, and HIPAA-compliant
patient derived xenograft (PDX) services. The overall objective of the MBSR is to provide UCDCCC members
access to technologies, services, and scientific consultation that assists, facilitates, and supports the
application of mouse models in cancer-related research. The MBSR is physically located in dedicated facilities
strategically located between the Davis and Sacramento campuses in close proximity to and fully accessible by
all UCDCCC members. By ensuring in vivo experimental reproducibility, reliability, cost-effectiveness, and
quality control, the MBSR supports and promotes scientific interaction and productivity of UCDCCC
researchers using mouse models to study cancer. Oversight and management of the MBSR is provided by the
Director, K. C. Kent Lloyd, DVM, PhD, a Professor of Surgery (SOM) and Associate Director for SRs for the
UCDCCC, who has extensive experience in mouse mutagenesis, phenotyping, and mouse modeling of
disease, including cancer. The interests and productivity of UCDCCC members have generated increasing
demand for mutant mouse services. With new genome editing capabilities (e.g., CRISPR/Cas9) and expansion
of PDX models, the contributions made by the MBSR to cancer research is projected to continue to expand
over the next 5 years. To enhance the scientific interaction and productivity of UCDCCC members, the MBSR
will continue to provide cancer-related research support services. The Specific Aims for the MBSR are to: 1)
Provide mouse modeling and creation services; 2) Provide mouse husbandry and maintenance services; and
3) Provide mouse genotyping and phenotyping services.